Neural Circuits Controlling Lacrimation

PROJECT SUMMARY
Tear secretion (lacrimation) is an essential mechanism that lubricates our eyes and helps reduce eye
irritants and microbial infections. Lacrimal deficiency is associated with many systemic or ocular diseases
including primary Sjögren's syndrome, lupus, dry eyes, congenital alacrima, and viral infections. Previous studies
have suggested that the superior salivatory nucleus (SSN) controls lacrimation. However, direct molecular and
genetic evidence is lacking. We recently identified a highly restricted neuronal population in mouse SSN. Ablation
of this neuronal population remarkably reduces lacrimation in mice, suggesting that this neuronal population
controls lacrimation. To test this hypothesis, we will first determine the efferent targets and physiological
properties of these SSN neurons (Aim 1). Results from these experiments will provide valuable information
regarding the encoding and transmission of lacrimal signals. Second, we will investigate the role of these SSN
neurons in controlling lacrimation by specific ablation or activation of this neuronal population (Aim 2). Results
from these experiments will provide functional evidence for SSN control of lacrimation. Finally, we will test these
SSN neurons receive sensory inputs from ocular surface and mediate reflex lacrimation (Aim 3). Results from
these experiments will help define previously unrecognized connections between ocular sensory inputs and SSN,
offering novel insights into the neural mechanism underlying the reflex lacrimation. In summary, our proposed
research will help reveal the neural circuit for lacrimation and provide foundational knowledge for future studies
of lacrimation deficiency associated with ocular or systemic diseases.

Public health relevance
PROJECT NARRATIVE Lacrimal deficiency is associated with many ocular or systemic diseases. This proposal will characterize the role of a newly-identified neuronal population in the superior salivatory nucleus in controlling lacrimation. These studies will advance our understanding of the neural mechanisms behind lacrimation and unravel new drug targets for treating lacrimal deficiency.